Development of a decision support tool for culturally adapting mental health treatment to improve outcomes for Latine youths

PROJECT SUMMARY
In the United States, racial-ethnic disparities in mental health treatment engagement and consequently rates of
unmet mental health needs have increased over the past two decades. Although drivers of these disparities
are multifaceted, key contributors include the fallacy that evidence-based treatments (EBTs) are acultural as
well as limited empirically supported guidance on culturally adapting EBTs. Developing a tool to help clinicians
decide whether, when, and how to culturally adapt EBTs for individual Latine youth clients may enhance the
cultural compatibility of EBTs and consequently improve treatment engagement and outcomes for this
underserved population. The overall objective of this research is to develop and pilot a novel tool to help
clinicians make personalized cultural adaptation decisions for their Latine youth clients. Our central
hypothesis is that this decision support tool will help clinicians make appropriate cultural adaptations to EBTs,
which will ultimately lead to improved mental health services and outcomes for Latine youths. In Aim 1, we will
develop a novel tool – the Culturally Responsive Assessment, Formulation, and Treatment Tool
(CRAFTT) – through four co-creation sessions with nine clinicians and researchers. These co-creation
sessions will involve activities to: (1) triangulate cultural factors that may influence treatment engagement or
progress to inform whether/when to culturally adapt EBTs; (2) triangulate cultural adaptations to inform how to
culturally adapt EBTs; (3) match cultural factors with corresponding cultural adaptations; and (4) determine
how to package this tool to facilitate effective and efficient clinician use. In Aim 2, we will refine CRAFTT
through usability testing with eight clinicians. Lab-based user testing (“think aloud”) observations and
quantitative usability ratings will be merged to identify and prioritize usability problems to be addressed through
CRAFTT refinements. In Aim 3, we will evaluate the feasibility of the approach intended to be used in a future
large-scale randomized effectiveness trial. This pilot study will include clinicians (N = 16) working with Latine
youths (N = 64) with anxiety, depression, trauma, and disruptive behaviors. Clinicians will be randomized to
either: (1) assess for cultural factors that may influence treatment engagement or progress using the Cultural
Formulation Interview (CFI), treat psychopathology using the Modular Approach to Treatment for Children
(MATCH), and make cultural adaptation decisions using CRAFTT; or (2) assess for cultural factors using the
CFI, treat psychopathology using MATCH, and make cultural adaptation decisions using their best clinical
judgement. Completion of this project will result in the first decision support tool for helping clinicians
personalize cultural adaptation of EBTs for Latine youths. This work will also lay the foundation for a NIH R01
grant proposing to conduct a large randomized effectiveness trial testing the effect of MATCH augmented with
CRAFTT on Latine youth treatment engagement and outcomes. This proposal aligns with NIMH’s priority to
adapt EBTs to improve mental health services for underserved populations and promote mental health equity.

Public health relevance
PROJECT NARRATIVE Incompatibility between evidence-based treatments (EBTs) and the cultural values, practices, and minoritized experiences of Latine youth and families contributes to racial-ethnic disparities in mental health treatment engagement and consequently mental health outcomes. The proposed study aims to develop and pilot a novel tool – the Culturally Responsive Assessment, Formulation, and Treatment Tool (CRAFTT) – for helping clinicians decide whether, when, and how to culturally adapt EBTs for individual Latine youth clients and thereby improve the cultural compatibility of EBTs for this underserved population. Completion of this study will result in a functional decision support tool designed to improve the quality and effectiveness of mental health services for Latine youths and promote mental health equity.